Building Brain Health Research Capacity in Rwanda: Neurocognition and Neurobehavior Across the Lifespan

PROJECT SUMMARY
RATIONALE: Neurological and psychiatric disorders collectively account for approximately 28% of the
global burden of disease, with the highest burden being found in low- and middle-income World Bank
countries (LMICs) where there are enormous barriers to healthcare. In this setting, there is a dearth of
clinicians and researchers trained in the neurosciences, limiting both access to care and research that
could impact outcomes.
OBJECTIVES: We propose the development of a brain health training program to increase expert brain
health research capacity and to develop valid and culturally relevant instrumentation to objectively
measure neurocognitive and neurobehavioral capacity. With this focus, we will create a cadre of
neuroscientists having the capacity to conduct research across all major disorders impacting the central
nervous system.
TRAINING PROGRAM: We have brought together leading experts in the neurosciences from Africa
(Uganda, Botswana, Congo, South Africa) and the US to create the Neurocognition and Neurobehavior
EXperts and Iest Instrumentation (NEXT) program in Rwanda. The proposed training program involves
academic instruction, practical laboratory experiences, and research criteria in three areas: brain health
(functional neuroanatomy, assessment, neurodiagnostics, neurorehabilitation), research (research design,
responsible conduct of research, neuroethics, statistics), and instrumentation (psychometrics). The NEXT
program tracks include a 3-year doctoral-level PhD track (8 students), a 2-year Master's degree track (6
students), and a single course track (up to 80 students). Two trainees will be selected for an intensive post
doctoral research fellowship at Emory University.
RELEVANCE: The overarching intended outcome of this program is to create the foundation of a
sustainable brain health program in Rwanda. This includes the introduction of a neuroscience-based
academic track at the University of Rwanda and the creation of a cadre of regional experts to conduct
independent research, mentor future clinician-scientists, and guide policy having brain health impacts.

Public health relevance
PROJECT NARRATIVE Collectively, neurologic and psychiatric disorders account for over a quarter of the global burden of disease, with disproportionately high rates of illness in low-middle income countries where expert resources are scarce. In order to create the expertise necessary to develop effective treatments, prevention and mitigation strategies, and public policy, we have developed a brain health research training program in Rwanda. This program will create the regional expertise and instrumentation needed to catalyze a sustainable brain health research program in Sub-Saharan Africa.